Outreach and Dessimination

COMPONENT SUMMARY (See instructions): The outreach and dissemination unit will use a variety of strategies to acquaint the larger Northwestern community, e.g., alumni, and students, fellows, and faculty at other institutions, with the mission and activities of the Network as a whole and with Northwestern's PS-OC in particular. The unit will also encourage and support collaborations between the NU PS-OC and outside investigators. These strategies include: • PS-OC website • Webcasts, podcasts • Annual symposium and related mini-symposia • Center brochure • Placement of articles about the PS-OC in NU print and electronic publications • Summer research experience for underserved college students • Support for collaborations with investigators outside of the Network